Modeling Adolescent Health Care Decision-Making for Vaccines: A Community- Based Participatory Approach

ABSTRACT
In the US, state and local laws allowing minors to consent to medical care can directly impact
population health. Prior research suggests increased vaccine uptake among adolescents in
states that allow minors to receive vaccines without parental consent. However, the impact of
real-world effects (e.g., vaccine hesitancy, access to vaccine providers) on this association is
unclear. It is also unknown if this association holds true for COVID-19 vaccines. Currently, the
percent of fully vaccinated 12-17-year-olds largely differs by state (from 11 to 61%), increasing
the risk of spread and negative health outcomes. Traditional efforts that apply mathematical
models to examine population-level outcomes do not account for different vaccine consent (VC)
laws, geospatial effects (e.g., spread within schools), local sociodemographics, or individual be-
haviors (e.g., vaccine hesitancy). To accurately study the impact VC laws as well as other real-
world effects have on COVID-19 transmission and mortality, researchers need to apply a com-
prehensive framework that integrates legal policy with health outcomes. Our proposed model
will apply a legal epidemiology framework that integrates legal and health data. It will leverage
US census data in an agent-based simulation (Framework for Reconstructing Epidemiological
Dynamics; FRED), which was designed to include system-level, sociodemographic, geospatial,
and individual effects in its simulation models. Our multidisciplinary team—with expertise in ado-
lescent health, health law, and computational modeling—will merge state- and local-level VC
laws with nationally representative census data within FRED. We will collaborate with commu-
nity partners—including minors, parents, school employees, and pediatricians, among others—
to understand the impact of VC laws on COVID-19 vaccine uptake, explore potential interven-
tions with different legal restrictions, and inform a simulation model. First, we will develop a
comprehensive legal dataset of state- and local-level VC laws for minors. Second, we will col-
laborate with community partners to understand the impact of VC laws and design potential in-
terventions. Third, we will model the effects of various laws, real-world effects, and potential in-
terventions in FRED to assess the impact of these factors on COVID-19 transmission. In sum-
mary, this project will result in a comprehensive legal dataset of VC laws for minors and an evi-
dence-based predictive model of COVID-19 spread and mortality in real-world conditions. The
model’s flexibility can inform researchers on the impact of various VC laws and other real-world
effects that can impact population health.

Public health relevance
NARRATIVE The goal of this project is to develop a legal dataset of vaccine consent laws for minors and to model the interplay between these laws and the spread and mortality of COVID-19, leveraging the power of nationally representative data and an agent-based simulation. The project team consists of a group of interdisciplinary researchers and community partners, allowing for a rigorous understanding of the impact of vaccine consent laws and the implications of potential interventions to increase vaccine update in adolescents. We will use an agent-based simulation to model the effects of vaccine consent laws and other real-world effects (e.g., vaccine hesitancy rates) in different locations to provide researchers with valuable information to inform future policy decisions and intervention development and implementation.